The spectrum of long non-coding RNAs that regulate HIV expression and latency

PROJECT SUMMARY / ABSTRACT
Establishment of the long-lasting latent reservoir and the low level of detectable HIV replication remain
stumbling blocks to cure from HIV infection. Long non-coding RNAs (lncRNAs), novel regulators of gene
expression, hold promise for development of HIV cure strategies, because they are more tissue and cell-type
specific than protein coding genes. Our long-term goal is to develop more potent strategies with higher
specificity than are currently available to target the latent HIV reservoir for reactivation or silencing. The overall
objective of this application is to evaluate the merit of using lncRNA-based approaches for HIV cure. Our
central hypothesis is that targeting single lncRNAs or their combinations will result in more robust effects on
HIV expression compared to existing strategies that use latency reversing (LRAs) or latency promoting agents
(LPAs). To test our central hypothesis, two specific aims will be pursued: (1) Identify lncRNAs with a role in the
regulation of HIV expression by conducting a CRISPR/Cas9 screen; (2) Identify overlapping functions of
lncRNAs using the RNA interactome of the HIV repressor zeste 2 polycomb repressive complex 2 subunit
(EZH2). For the CRISPR/Cas9 screen, JLat cell lines constitutively expressing Cas9 will be generated and
transduced with the sgRNA library to target lncRNA splice sites. To identify lncRNAs that act as HIV
repressors, cells will be screened in the resting state. When repressive lncRNAs are knocked out, sgRNAs are
expected to be enriched in the population of HIV-producing cells that express GFP reporter protein. To identify
lncRNAs that act as HIV activators, the fraction of cells that remain GFP-negative after initial lncRNA knockout
will be treated with tumor necrosis factor (TNF) alpha. When lncRNAs that contribute to HIV activation are
knocked out, sgRNAs are expected to be enriched in the population of cells that remain GFP-negative
following treatment with TNF alpha. For identification of overlapping functions of lncRNAs, EZH2 has been
selected because it is an HIV repressor that has several known lncRNA interacting partners. We will identify
the entire lncRNA interactome of EZH2 using the enhanced UV cross-linking and immunoprecipitation (eCLIP).
Selected lncRNAs from the screen and the EZH2 interactome will be knocked down individually and in
combinations in JLat and primary CD4+ T cells, and effect on HIV expression will be compared to that induced
by LRAs and LPAs. We will further conduct chromatin immunoprecipitation to determine whether knockdown of
identified lncRNAs affects EZH2 occupancy of the HIV promoter. Because eCLIP will result in identification of
specific sequences of the lncRNAs that interact with EZH2, we will mutate these sequences to determine
whether interaction with EZH2 is responsible for the observed activator or repressor phenotype. These results
will be significant because they will provide strong scientific justification for development of lncRNA-based
therapeutic interventions to reactivate latent HIV or enhance viral suppression on antiretroviral therapy. For
example, small molecules can be used to specifically disrupt interactions between lncRNAs and proteins.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it aims to explore long non-coding RNAs, a novel class of gene expression regulators, for development of new HIV cure strategies. In particular, it aims to conduct an unbiased screen to identify all candidate long non-coding RNA targets, and explore their overlapping functions. The proposed research is relevant to the part of NIH's mission that pertains to enhancing health and reducing the burdens of illness, specifically, the NIAID mission to fight HIV/AIDS.